The influence of estrogen on the thermoregulatory responses to heat stress in pre and postmenopausal women

PROJECT SUMMARY
As average global temperatures continue to rise, the frequency, duration, and severity of extreme heat events
are also increasing. Further, the population of aged adults is increasing globally, resulting in a larger population
of those who are most vulnerable to heat-related morbidity and mortality. Recent heat waves report older women
(65+ yrs) as the most vulnerable group during extreme environmental heat events due to an inability to maintain
heat balance at lower temperature and humidity combinations than age matched men. Female reproductive
hormones alter thermoregulatory responses to heat stress through central and peripheral mechanisms.
Reductions in reproductive hormones throughout and after menopause could mediate this age specific sex
difference, however, the extent to which the increase in heat vulnerability in older women can be attributed to
menopause-induced estrogen reductions separate from age-related physiological declines is unclear. The
purpose of the current study is to determine the independent role of estrogen on reflex control of cutaneous
vasodilation and sweating in pre and postmenopausal women of equal age. Through an estrogen knock down
and add back model, we will mechanistically examine the impact of estrogen on thermoregulatory mechanisms
during passive whole-body heating. Our global hypothesis is that estrogen mitigates age-related impairments in
convective and evaporative heat loss and reductions in estrogen throughout the menopause transition
accelerates the aging process, impairing thermoregulation and increasing heat vulnerability. This project and
associated training plan will serve as a vehicle for exceptional predoctoral training for the candidate.

Public health relevance
PROJECT NARRATIVE Women over the age of 65 are the most vulnerable during extreme environmental heat events, experiencing worse health outcomes than men of equal age, and any other age group. Primary aging and female reproductive hormones directly alter the thermoregulatory responses to heat stress, however, whether menopause-induced hormone fluctuations mediate this age and sex specific increased heat vulnerability is unknown. The current proposal aims to mechanistically examine the impact of estrogen on reflex vasodilation and sweating in pre and postmenopausal women of equal age during passive whole-body heat stress.